Sigma 1 Receptor: a novel therapeutic target for retinal degeneration

PROJECT SUMMARY Blinding retinopathies constitute an urgent unmet healthcare need demanding novel therapeutic strategies. Retinal degenerative diseases are the major cause of untreatable blindness worldwide and frequently involve photoreceptor cell (PRC) death. Recently, we reported dramatic rescue of cone PRC function in the Pde6brd10/J (rd10) mouse model of retinopathy when mice were treated systemically with (+)-pentazocine ((+)- PTZ), a high affinity ligand for sigma 1 receptor (σ1R). σ1R is a transmembrane protein considered a molecular chaperone involved in the ER stress response. Studies support the notion that σ1R modulates ER stress and Ca2+ signaling in retina. However, new data show that σ1R localizes also to the nuclear membrane of several retinal cell types (RGC, PRC, and Müller cells) suggesting that attenuation of ER stress may not explain entirely the mechanism(s) by which σ1R mediates retinal neuroprotection. We postulate that a novel mechanism underlying the robust retinal neuroprotection afforded by σ1R activation is modulation of the Nrf2- Keap1 pathway. Nrf2 is arguably the most important antioxidant molecule in cells because it regulates transcription of more than 500 antioxidant/cytoprotective genes. In the absence of stress, Nrf2 is retained in the cytoplasm by Keap1 and excess Nrf2 is degraded by the proteasome. However, under cellular stress, Keap1 releases Nrf2, which then translocates to the nucleus to activate “antioxidant response elements” (ARE) of genes that encode numerous cell defense proteins and enzymes. Oxidative stress is a major pathogenic factor underlying PRC degeneration. It significantly increases binding of (+)-PTZ to σ1R. We know that (+)-PTZ treatment of rd10 mice modulates retinal Nrf2 levels, antioxidant gene expression and protein/lipid peroxidation, however we do not know whether Nrf2 is central to these retinal neuroprotective effects. Aim 1 will test this by evaluating the extent to which Nrf2 is sufficient and essential to rd10 PRC rescue. We know that σ1R interacts functionally with Nrf2-Keap1 in primary Müller cells; however we do not know the extent to which it alters function of or interacts with proteins in the pathway. Aim 2 will test this by evaluating the extent to which (+)-PTZ treatment alters Nrf2-Keap1 gene/protein expression, Nrf2 nuclear translocation, Nrf2 ARE activation, Keap1 inhibition, and Nrf2 proteasomal degradation in WT and σ1R-/- Müller cells and will evaluate σ1R interaction with members of the Nrf2-Keap1 pathway. Finally, we know that (+)-PTZ can rescue cone PRC in rd10 mice through post-natal day (P)42; however we do not know the extent to which (+)-PTZ treatment can delay cone death in rd10 mice beyond this age nor whether the effects are generalizable to other σ1R ligands. Aim 3 will test this by evaluating retinal function/structure in (+)-PTZ-treated rd10 mice over an extended time course and will assess efficacy of two other σ1R ligands. In summary, promising data form the basis of our proposal, which explores a novel mechanism by which σ1R activation mediates PRC rescue and investigates the extent to which the phenomenon is sustainable and generalizable to other σ1R ligands.

Public health relevance
PROJECT NARRATIVE The major cause of untreatable blindness worldwide is retinal degenerative disease, frequently due to retinal ganglion or photoreceptor cell loss. Strategies to retard retinal diseases and/or to restore vision are needed desperately. This proposal examines activation of sigma 1 receptor (σ1R) as a novel neuroprotective target for treatment of retinal disease and investigates whether the mechanism by which σ1R mediates neuroprotection involves modulation of the Nrf2-Keap1 pathway.